Ex vivo single molecule tools to analyze membrane receptor dynamics

Membrane receptors play a crucial role in many physiological processes throughout the body by
mediating communication between cells. Single molecule imaging has been used extensively to
study membrane receptor assembly and stoichiometry in vitro using isolated protein and to a
lesser extent cell culture. While studies in isolated cellular systems provide insight into many
processes, they lack the context of the complex environment present in an animal where
communication between cell types residing in tissue is critical for receptor activity. Single-
molecule imaging of native proteins synthesized in vivo would provide a direct approach to
measure processes, such as receptor dimerization, that regulate physiological activity. However,
current methods are not capable of applying single molecule techniques to study the regulation
of protein dynamics taking place within the complex environment of an animal. We have made
recent advances in the development of ex vivo single molecule techniques to monitor changes in
protein assembly that occur within specific organs. The goal of this proposal is to develop and
validate ex vivo single molecule tools that provide new capabilities to monitor the properties of
oligomeric membrane receptor assembly, resolve cell type and subcellular region specific single
membrane receptors, and automate single molecule data analysis using a machine learning
platform. This novel ex vivo technology will enable researchers to take a snap shot in time of the
membrane receptor dynamics that took place in the mouse and monitor changes in membrane
receptor assembly in response to changes in the animal's physiological environment such as
disease and exposure to therapeutics.

Public health relevance
Membrane receptors are important therapeutic targets for many diseases and are expressed throughout the body. Understanding the role of receptor assembly in the complex environment of a live animal is an important step in understanding their mechanism of activation and regulation. We will develop ex vivo single-molecule methods that for the first time will enable quantitative studies of stoichiometry for receptors extracted from mice.